Reporter Mice For APP Processing And Transport

DESCRIPTION (provided by applicant): The long-term goal of the proposed research is to characterize and understand the modifications in axonal transport in Alzheimer's disease (AD). Although it was suggested that an abnormal axonal transport could contribute to AD pathology, no systematic study was conducted. Here, we aim to cover this gap. We begin by asking how the amyloid-β precursor protein (APP), a type I transmembrane protein that is at the core of the pathogenic process in AD, is transported to the site(s) of its function within neuronal processes, in normal and in disease-related conditions. This study should have a strong impact on human health. APP, the precursor of the amyloid-β peptide that forms the senile plaques in AD, is proteolytically cleaved, by the action of secretases, into soluble, N-terminal (sAPP) and C-terminal (CTF) polypeptides. We recently showed that, in neurons, proteolytic processing of APP into fragments largely occurs prior to sorting into cargo vesicles, and that the different APP-derived polypeptides are transported independently (by distinct vesicle populations) to different destinations (Muresan et al., 2009. J. Neuroscience, 29: 3565-3578). To begin characterizing APP transport we will start with characterizing the transport of full-length APP and of the APP-derived N- and C-terminal fragments. To achieve this goal, we will generate knock-in mice that express APP, tagged with different reporters at its termini, which will allow separate tracking of the APP's N- and C-terminal fragments. Most importantly, because the dual-tagged APP will be knocked into the endogenous APP locus by homologous recombination (to maintain the endogenous regulatory elements for APP expression), the dual-tagged APP will be expressed at endogenous levels. We propose two Specific Aims. In Specific Aim I, we will generate the knock-in mice that will allow us to analyze the processing, transport, and localization of APP, and investigate the spectrum of proteins that interact with the APP's N- and C-terminal fragments. With in vivo motility assay, in Specific Aim II we will analyze the transport of APP-derived polypeptides in the neurons from the knock-in mice expressing CFP-APP-YFP (with CFP and YFP tagging the APP's N- and C- termini). An additional knock-in mouse expressing FLAG-APP-myc will be useful to determine with biochemical and subcellular fractionation methods the organelles where the APP fragments target, and the different sets of proteins that cotransport or interact with APP polypeptides. Finally, this study will emphasize the relation between the transport, processing, and function(s) of APP, and will increase the understanding of APP biology in the context of AD.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project is directly relevant to Alzheimer's disease (AD), a neurodegenerative disorder predicted to affect 14 million individuals by 2050. The proposed work will generate novel mouse lines for the in vivo study of the processing and transport of APP, the protein at the core of the pathogenic process in AD. This study will provide unique tools for a better understanding of AD at molecular level, and could potentially lead to the design of novel treatment strategies aimed at improving axonal transport. This project is directly relevant to Alzheimer's disease (AD), a neurodegenerative disorder predicted to affect 14 million individuals by 2050. The proposed work will generate novel mouse lines for the in vivo study of the processing and transport of APP, the protein at the core of the pathogenic process in AD. This study will provide unique tools for a better understanding of AD at molecular level, and could potentially lead to the design of novel treatment strategies aimed at improving axonal transport. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Main question: Our long-term goal is to determine whether and how the axonal transport is altered in Alzheimer's disease (AD). We ask how the amyloid-β precursor protein (APP), a type I transmembrane protein relevant to AD, is transported to the site(s) of its function, in normal and in disease-related conditions. Since abnormal transport of APP could contribute to the pathology of AD, this study should have a strong impact on human health. The premises: APP is proteolytically cleaved into polypeptides, including the amyloid-β peptide (Aβ) and the C- and N-terminal fragments (CTFs and NTFs). While most studies focused on the toxicity of Aβ, the potential pathogenic role of the CTFs and NTFs was occasionally considered. This role is dependent on where and how the APP metabolites are generated, sorted from each other, transported, and targeted. It is also dependent on the functional interactions between the CTFs and NTFs and other proteins, and where these interactions occur. Altered transport of APP could result in modifications in APP processing and altered targeting to its site(s) of fumction, leading to disease. The biology of APP is far from being understood. APP is not overexpressed in humans that develop AD, yet much of our understanding of APP biology, including processing and transport, has come from overexpression studies. Transgenic mouse models of AD express APP mutants at levels that are several-fold higher than that of endogenous APP. Using neuronal cell cultures, we recently made two seminal observations that prompted the studies proposed here: (1) Immunolocalization studies with antibodies to different APP epitopes showed that a significant fraction of the C- and N-termini of APP segregate in separate transport vesicles, and accumulate at distinct locations within neurites; this is consistent with transport of the CTFs and NTFs, rather than of full length APP [1]. (2) When APP is overexpressed, the processing of APP into fragments is diminished, and most APP is transported into neurites as full-length protein rather than CTFs and NTFs [1], a reversal from the normal situation. Thus, the transport and the processing of APP, including that of AD-specific APP mutants, require to be reinvestigated in conditions of normal levels of expression of APP. The hypotheses: These premises suggest that: (1) APP processing normally occurs early in the secretory pathway, and (2) the CTFs and NTFs of APP are sorted into separate vesicles that are independently transported into neurites (Fig. 1). These hypotheses will be tested with mice that express APP carrying distinct tags at the C- and N-termini. The dual-tagged APP will be inserted into the APP locus by homologous recombination, replacing the endogenous APP, and will be expressed from the natural promoter of APP at levels similar to normal. The goal of this proposal is to generate, and begin characterizing these transgenic mice. Fig. 1. Diagram showing two possible trafficking pathways of APP: (1) Transport of full-length APP; (2) Independent transport of cleaved C- and N-terminal fragments of APP, segregated into distinct vesicles. Specific Aim I. In vivo imaging of processing and transport of APP with mouse models I.1. Generation of CFP-APP-YFP and Flag-(Cys4)-APP-Myc expression constructs I.2. Generation of knockin mice expressing CFP-APP-YFP or Flag-(Cys4)-APP-Myc under the control of endogenous APP promoter Specific Aim II. Characterization of the knockin mice expressing dual-tagged APP II.1. Histological and behavioral analysis II.2. Analysis of expression, processing, and localization of dual-tagged APP II.3. Preliminary analysis of APP transport into neurites: full-length APP versus cleaved C- and N-terminal fragments